Urine based circulating tumor DNA analysis

Urine is an underappreciated source for systemic circulating tumor DNA in patients with non-genitourinary
cancers. Based on recent data suggesting that blood-based HPV DNA testing is useful for disease monitoring
in HPV positive oropharynx cancer patients, we identified non-metastatic HPV positive oropharyngeal cancer
patients as an excellent model system to examine the potential of urine-based transrenal DNA analysis. Our
preliminary data suggests that our newly developed urine-based HPV test could have biomarker performances
comparing favorably to blood-based HPV testing. The specific objectives of this application are to establish that
urine is a suitable source for HPV DNA in non- metastatic HPV positive oropharynx cancer patients, and that
at-home urine based molecular testing is feasible for these patients. Specifically, we will compare sensitivity
and specificity of pre-therapy urine-based HPV testing to tissue gold standard testing in a cohort of newly
diagnosed non-metastatic oropharyngeal cancer patients. Recurrence detection lead time of urine-based HPV
testing will be compared to clinical routine care in the same cohort after curative intent treatment. Controls will
include blood-based HPV testing, pharyngeal swab-based HPV testing and blood based personalized ctDNA
sequencing panel testing. Additional control cohorts will include cervical and anal cancer patients as well as
cancer-free patients with recently diagnosed oncogenic HPV infections. Using in vivo fluorescence imaging
techniques, we will generate fundamental knowledge on renal handling of cell free DNA and determine the
impact of chronic kidney disease and other patient, disease and iatrogenic factors on cell free DNA excretion.

Public health relevance
NARRATIVE We developed a novel urine-based HPV test, with test performances comparing favorably to blood-based HPV testing. Using this test, we obtained preliminary data suggesting first details of the physiological processes underlying blood cell free DNA excretion into urine. The parent proposal will expand on these findings and explore the potential of our test as a biomarker in oropharyngeal cancer patients undergoing curative intent radiation therapy. The supplement proposal will further develop our large volume urine processing methods.